NHLBI ENTERPRISE RISK MANAGEMENT (ERM) PROGRAM TASK AREA C - UPDATING LCAT

The NHLBI Enterprise Risk Management Program (ERM) supports risk identification, assessment, evaluation, and reporting across the breadth of NHLBI's diverse operational and scientific portfolios.